Structural determinants of healthy aging: Assessing the role of governmental spending priorities in early life on mid-life cognition, later-life dementia risk, and racial inequity therein

PROJECT SUMMARY/ABSTRACT
Alzheimer’s Disease and Related Dementias (AD/ADRD) affect 15% of older US adults, with greater burden
among those who are racially minoritized. Experiences in early life (e.g., differential exposure to childhood
adversity) contribute to racial inequity in AD/ADRD risk. Population distributions of these early life experiences,
however, are themselves shaped by upstream factors that remain underexplored in the AD/ADRD literature.
National, state, and local governmental investments in public goods, and which goods are prioritized, are one
such set of intervenable upstream factors conditioning early life across place and time. For example, in 1965
the Elementary and Secondary Education Act facilitated intergovernmental grants (from federal to local
governments via states) to enhance educational programing. By the 1980s, however, educational investments
were outpaced by prison/jail expenditures, with racially minoritized communities disproportionately targeted.
While upstream factors like governmental investments in early life could be linked to AD/ADRD inequity, and
therefore serve as a structural lever for primary prevention, this has yet to be empirically tested.
This K99/R00 leverages a novel longitudinal governmental spending database and two large, nationally
representative, prospective datasets (National Longitudinal Survey of Youth 1979; US Health and Retirement
Study) to estimate effects of federal, state, and local governmental investments in early life on midlife cognition
and later life AD/ADRD risk. Triangulating across the strengths of confounder-control and quasi-experimental
methods, this K99/R00 advances a nascent evidence base by (1) examining if county legal system or K-12
education investments in early life are independently associated with overall risk for or inequity in midlife
cognition and later life AD/ADRD; (2) characterizing how county legal system and K-12 education investments
jointly co-vary over early life and evaluating if investment co-occurrence is associated with overall risk for or
inequity in midlife cognition and later life AD/ADRD; and (3) examining if early life exposure to federal policies
monetarily investing in K-12 education affects midlife cognition, later life AD/ADRD, and inequity.
Under the guidance of an expert, multidisciplinary mentorship team, the accompanying training plan builds on
the candidate’s subject matter and methodological background with additional skill building in the clinical/
epidemiologic dimensions of AD/ADRD and its racialized and gendered lifecourse determinants; database
development; methods for characterizing longitudinal exposures; and quasi-experimental analysis methods.
The proposed research aligns with several NIA strategic goals on identifying environmental and social factors
in early life that create and sustain disparities among older adults. Further, it initiates evaluation of early life
governmental spending as a potential structural determinant of cognitive aging, develops a novel dataset –
linkable to any individual outcome data – for future work, and is designed to directly inform prevention efforts.

Public health relevance
PROJECT NARRATIVE Experiences in childhood and adolescence (e.g., differential exposure to childhood adversity) contribute to racial inequity in risk for Alzheimer’s Disease and Alzheimer’s Disease Related Dementias (AD/ADRD). Population distributions of these early life experiences, however, are themselves shaped by upstream, structural factors that remain underexplored in the AD/ADRD literature. The proposed research will be the first to examine the implications of federal, state, and local governmental spending priorities – as structurally intervenable exposures that condition early life environments – on overall risk for, and racial inequities in, midlife cognition and later life dementia, providing important information to support government officials in prioritizing investments that facilitate and sustain lifecourse health.